Genetic and biophysical causes of historical protein evolution

My lab develops and applies new approaches at the interface of molecular evolution and protein
biochemistry . We have played a lead role in developing ancestral protein reconstruction (APR) with
molecular experiments as a powerful strategy to decisively identify the genetic, biophysical, and evolutionary
mechanisms by which extant proteins evolved new functions. We recently expanded this approach by
conducting the first studies to use deep mutational scanning of massive protein libraries to characterize the
distribution of functions in the sequence space around ancestral proteins; this allows us to compare the
trajectories taken during history to the vast number of alternative paths that could have been taken, thus
providing insight into the roles of functional optimization, neutral chance, epistasis, and historical
contingency in shaping the trajectories and outcomes of protein evolution. In the next 5 years, we will
further develop these approaches and apply them to two major problem areas:
1) Evolution of complex protein features. Many proteins assemble into specific multimeric
complexes and are functionally regulated by binding to allosteric effectors. These features usually many
interacting residues, so it has been difficult to identify the evolutionary genetic and biochemical mechanisms
by which they originate during evolution. We will use APR and vertebrate hemoglobin as an ideal model
system to dissect the particular historical mutations and consequent changes in physical properties that
cause this essential protein to acquire multimerization and allostery from a simpler precursor.
2) Comprehensive assessment of the functional, fitness, and epistatic effects of
substitutions during long-term protein evolution. Targeted experiments have shown that mutations
often epistatically modify the effects of other mutations in the same protein; theory and case studies suggest
these dependencies can make evolutionary paths and outcomes contingent on chance events. There have
been no comprehensive studies, however, to characterize the extent of epistasis among the full set of
substitutions that occurred during history, their effects on evolutionary processes, or the temporal dynamics
by which these effects emerge. We will use high-throughput protein library assays on ancestral proteins to
measure the functional and fitness effects and epistatic interactions of all substitution that occurred across
long, well-resolved historical trajectories, determine how shifts in these effects over time affected
evolutionary processes, and analyze how underlying biophysical mechanisms mediated these effects.
As in our past work, we expect these new strategies to generate strongly supported new knowledge
concerning the mechanisms and forces that drive protein evolution, and that our approaches will be adopted
by other groups to deepen our evolutionary and biochemical understanding of other protein families.

Public health relevance
Narrative The goals of this proposal are to combine evolutionary and biochemical analysis to discover the genetic and structural mechanisms that caused the evolution of protein functions that play major roles in health and disease, including allosteric regulation of protein activity, formation of multimeric complexes, regulation of gene expression by transcription factors, and support for protein folding by chaperones. A better understanding of the genetic causes an consequence of protein evolution will allow more accurate interpretation of patterns of conservation and variability among modern-day proteins, improve our ability to predict the effects of genetic variation on health and disease, and aid in the design of proteins with desired properties.